CORE--SURVEY METHODS

Description: (Applicant's Description) The Survey Research Laboratory, University of Illinois, Chicago, will serve as the Survey Methods Core of the CISRC renewal. The Survey Methods Core will be responsible for all telephone interviews scheduled at 3 and 12-14 months follow-up. These interviews will provide outcome data for evaluating the CISRC interventions. The Survey Methods Core will also be responsible for pretesting and developing final versions of all survey instruments. The Survey Methods Core will transfer interview data to the Biostatistical Core for subsequent transfer to the Tailored Message Core. The Survey Methods Core will also transfer data to the Biostatistical Core for analysis. Significant features of this core resource include: * experienced senior leadership; * a well established track record as the Survey Methods Core in the current CISRC; * extensive collaboration in the design of the CISRC renewal application; * the proposed use of the latest cognitive theories regarding survey response to reduce non-sampling error resulting from poor questionnaire design; and * exemplary survey fieldwork capabilities and quality control.